Chemical proteomics strategies for quantifying inflammatory protein networks and modifications

The overall vision of the research program is to investigate inflammatory signaling pathways regulated by pattern
recognition receptors (PRRs), such as Toll-like receptors (TLRs) and NOD-like receptors (NLRs), at the
molecular level using innovative mass spectrometry-based chemical proteomics technology. TLRs, NLRs, and
other PRRs play central roles in several diseases, including infectious, inflammatory, and cancer. While
biomedical research over the past decade has significantly advanced our understanding of the physiological
function of several TLRs and NLRs, the precise mechanisms by which diverse PRRs are activated by pathogen-
and danger-associated molecular patterns, as well as the biochemical processes and molecular interactions
involved in activating downstream signaling pathways, remain poorly understood. Moreover, the physiological
functions of many PRRs are yet to be defined. New quantitative proteomics methods are urgently needed to
dissect the full spectrum of NLR and TLR host-defense signaling pathways.
A systems-level understanding of interactome, and post-translational modification (PTM) networks
requires cutting-edge proteomics methods. The major challenge at this moment is the reliable identification and
quantification of interactome and PTMs in large-scale studies. Interactome networks are complex and require
specific pull-down methods or system-level experiments for unambiguous identification of protein complexes and
their modifications. Efficient methods to study transient and weak interactions should be developed to preserve
the integrity of protein complexes after cell lysis. PTMs are present in low abundance, and their diverse structures
require new methods for confident identification in large-scale samples. Chemistry-based approaches combined
with mass spectrometry (MS) have become popular due to their ability to pinpoint interactome and enrich low
abundance modifications; furthermore, different features can be incorporated into chemical structures, allowing
for confident identification by mass spectrometry. In this regard, gas-phase selective cleavage of chemical bonds
in a mass spectrometer has become useful because modified peptides can be traced by a signature mass
generated in the mass spectra. This signature mass enables efficient analysis of large-scale samples. This
research plan outlines comprehensive chemical strategies designed to quantify system-level protein-to-protein
interactions and develop cutting-edge methods to profile post-translational modifications of proteins. These
methods will be applied to decipher the host-defense interactome and PTMs of several TLRs and NLRs upon
exposure to external and environmental agents. The outcomes of this research will contribute to the design of
novel drugs to treat aberrant inflammations caused by excessive activation of TLRs and NLRs and will enable
comprehensive study of several biological systems.

Public health relevance
This study will develop cutting-edge proteomics strategies to enhance our understanding of dysregulated inflammation caused by environmental and external agents. We anticipate that our research, aimed at identifying potential new drug targets to combat inflammation, will likely provide fundamental insights into immune signaling relevant to a broad array of inflammatory diseases.